TRAINING PROGRAM IN BIOMEDICAL IMAGING AND INFORMATIONAL SCIENCES

Principal Investigator/Program Director (Last, First, Middle): Gee, James C.
Project Summary
The training of quantitative basic scientists in clinically-related imaging science is increasingly important.
Excellent imaging sciences are well represented at Penn in multiple schools, but previously no formal
integration of efforts in graduate training existed, nor was there a formal clinical component to the training until
the creation of the Training Program in Biomedical Imaging and Informational Sciences. Established in 2006
under the auspices of the HHMI-NIBIB Interfaces Initiative, today the program represents a partnership led by
the Departments of Radiology, Bioengineering, and Computer and Information Science, in collaboration with
many other Departments across multiple Schools. Our premise is that the most successful research and
technologies in quantitative imaging science are those that integrate clinical relevance, mathematical rigor, and
engineering finesse. Accordingly, the program embraces strong clinical exposure alongside analytical imaging
science. The objective is to provide interdisciplinary training by ensuring that students attain a level of
integration that will allow them to become the next generation of leaders in hypothesis-driven, clinically-focused
biomedical imaging research. Program outcomes to date are strong across all impact measures, indicating
successful progress toward training objectives: publications (219) and citations (5171); numerous research
awards and distinctions; recruitment of 9 (23%) URM or disadvantaged trainees; and 14 graduates (78%) in
faculty positions, post-doctoral training, or medical training and residencies.
A formalized curriculum, the doctoral foundation, developed for the program provides 18 months of vertical
integration of the core didactic elements of biomedicine and basic science education in biomedical imaging
through three Foundational components, followed by elective Pathways. In the first, Foundations in Biomedical
Science (2 courses), students participate in modules 1 and 2 of the medical student curriculum that teaches
the Core Principles of Medicine (including Gross Anatomy) and a 12-month sequence of organ systems
medicine, Integrative Systems and Diseases. This is complemented by 2 courses in Foundations of Imaging
Science: Molecular Imaging, and Fundamental Techniques of Imaging. The third foundational component is
Professional Training: Responsible Conduct of Research, Scientific Rigor and Reproducibility, Teaching
Practicum, Patient-Oriented Research Training, Research `Survival' Skills, and Career Development Skills. The
foundational curriculum is extended toward more specialized training by many elective courses offered through
two Pathways – Imaging Methods and Applications, and Imaging Data Science – the latter new in the next
renewal period. Didactic training is complemented by obligatory Laboratory Rotations that are offered through
the laboratories of participating faculty. To ensure that the thesis research is directed to translational medicine
through the solution of discrete clinical problems, trainees are required to be co-advised by members of the
clinical and basic science faculty.
PHS 398 (Rev. 11/07) Page Continuation Format Page

Public health relevance
Principal Investigator/Program Director (Last, First, Middle): Gee, James C. Project Narrative Imaging science is essential in current medical practice and to the future of diagnostic, interventional, and prognostic medicine. However, the PhD training of US imaging scientists, critical for research advancements in this interdisciplinary field, is deficient in formal training in anatomy, physiology, basic biomedicine and the clinical considerations that factor into clinical imaging. Our program addresses this deficit by immersive medical school coursework concomitant with a growing body of advanced training experiences in imaging and by recognizing that exceptional students are more than capable of meeting the demands of a vertically integrated program. Our ultimate goal is to expand this new kind of interdisciplinary training, ensuring that more students can attain a level of integration that will allow them to become the next generation of leaders in hypothesis-driven, clinically-focused biomedical imaging research. PHS 398 (Rev. 11/07) Page Continuation Format Page